A single cell view of the spatiotemporal nitrogen response in roots

Project Summary/Abstract: This proposal seeks to investigate the mechanisms that mediate nutrient control
of lateral root (LR) development by exploiting new single-cell expression data. The ultimate goal is to develop
plants with enhanced nitrogen (N)-uptake and N-use-efficiency (NUE). This would help ameliorate the application
of excess N-fertilizer - a main cause of water and air pollution that negatively impacts human health. Plant roots
can sense levels of nitrate in the soil, which induces LR foraging for nutrients. LRs initiate post-embryonically
from differentiated cells in the pericycle layer of the root, which de-differentiate to form “founder cells” that give
rise to the post-embryonic LRs meristems. Thus, LRs are vital for root developmental plasticity and nutrient
acquisition. Previous studies using GFP-marked cell lines, found that N-responses in roots are cell-type specific.
However, those studies lacked the single-cell resolution and time-component necessary to identify the N-
regulation of transitional states of cell-types (i.e. pericycle-to-founder cell). This proposal aims to: i) use single-
cell N-response time-series data to create developmental trajectories that model the transition from pericycle-to-
founder cells and ii) identify/validate TFs that regulate LR initiation in response to N-sensing. To do this, single-
cell N-response transcriptome data will be analyzed from N-treated Arabidopsis thaliana roots (Aim 1). To
determine the TFàtarget gene relationships in this dataset, cell-specific N-response data will be used to learn
gene regulatory networks (GRNs) using a time-based machine learning algorithm called OutPredict. Next, the
predicted TFàtarget gene interactions in the GRN will be validated using TARGET, a root cell-based TF
perturbation assay (Aim 2). Finally, the function of candidate TFs in N-regulation of LR development and N-
uptake will be validated in planta using TF mutants in phenotyping assays (Aim 3). In a preliminary in silico
analysis of the outlined approach applied to existing single-cell data from Arabidopsis roots, intersected with N-
responsive transcriptome data from whole roots identified: 1. A founder cell pseudotime trajectory and N-
responsive TFs (Aim 1), 2. A founder cell N-response GRN that predicts TFàtarget gene interactions, and 3. A
preliminary list of N-response TFs from founder cell trajectories (Table 2). These preliminary TFs will be
phenotyped for their role in N-responsive LR development and 15N-uptake (Aim 3). This proposal will be the first
to collect single-cell N-response data in planta and model LR development using developmental trajectory
approaches. This proposal also provides new computational training in single cell-data analysis and machine
learning methods for GRN to the PI, which will complement her experimental skills-set in plant molecular biology,
and provide her with a multi-faceted research foundation for a career as an independent researcher. This project
will also benefit from a sponsor environment with proven success for providing new training to the PI, as well as,
the ideal laboratory and collaborator environment for the for the proposed single-cell and network modeling
experiments.

Public health relevance
Project Narrative: The developmental plasticity of plants is enabled by their ability to change their root architecture post- embryonically, to acquire water and nutrients in a changing soil environment. This study specifically aims to identify the mechanisms by which nitrogen initiates the development of post-embryonic meristems in lateral roots. These studies will be used to guide strategies for generating crops that have enhanced lateral root growth and are more efficient at taking up nitrogen in the soil, to reduce the excess application of nitrogen-based fertilizes that negatively impact the environment and human health.